Impact of School-Based Health Centers on Improving Health and Promoting Equity

Project Summary
Disparities in health outcomes and access to care for children and adolescents are large and persistent, with
worse outcomes observed among children and adolescents who are Black and Hispanic, enrolled in Medicaid,
live in low-income households, and live in rural areas. School-based health centers (SBHCs) may help to
promote health equity by making care more accessible and affordable to school-aged children, meaning
SBHCs are well-positioned to reduce disparities in health care use and health outcomes. Prior research
generally suggests benefits from SBHCs. However, most studies only examine a few SBHCs and report
correlational associations rather than causal evidence. This proposed study of SBHCs in California and
Oregon will overcome the limitations of prior studies by using a large sample and rigorous causal inference
methods. Because both states have experienced recent growth in SBHCs, we will exploit variation in
availability of SBHCs over time and across schools to compare the impact of SBHCs on students before and
after the opening of SBHCs in treatment schools (with SBHCs) and control schools (without SBHCs). Using
multiple years of health insurance claims data, survey data, and education data, we will: (1) characterize
SBHCs, including the services they provide, the patients receiving care at SBHCs, and changes since the start
of the COVD-19 pandemic; (2) estimate the impact of SBHC access on health care utilization, cost, health
outcomes, and education outcomes overall and for members of health disparity populations (defined by
race/ethnicity, household income, and rurality); and (3) examine the dimensions on which SBHC
characteristics vary, including location, services offered, size, and the pandemic to inform the operation of
current SBHCS and design of future SBHCs. The proposed research is timely and important due to
longstanding and new barriers to health care and the increasing recognition of the importance of schools in
promoting the healthy development of children and adolescents.

Public health relevance
Project Narrative This project will examine the impact of school-based health centers (SBHCs) in California and Oregon on health care utilization, cost, health outcomes, and education outcomes overall and for members of health disparity populations. By using multiple years of health insurance claims data, survey data, education data, and information on students' access to SBHCs, we will estimate the causal impacts of students' access to SBHCs in a difference-in-difference model which leverages variation in the availability of SBHCs over time and across communities. We will also examine the dimensions on which SBHC impacts vary, including location, services offered, size, and the pandemic to inform the operation of current SBHCs and design of future SBHCs.